Uncovering novel gene regulatory mechanisms underlying glucocorticoid response phenotypes through targeted mutagenesis of an essential transcription factor

ABSTRACT
Hormone signaling and endocrine therapies are critical to human health. Genetic variation altering endocrine
responses contributes to the risk of developing endocrine disorders and metabolic diseases. A predominant
mechanism underlying altered endocrine responses involves coding variants in the transcription factors (TF)
regulating these signaling pathways. Characterizing the regulatory effects of TF coding variants en masse
remains challenging, thus limiting our understanding of how key endocrine pathways are controlled. To change
this paradigm, the objective of this proposal is to determine how pathogenic coding variants in the
glucocorticoid receptor (GR), a major and representative regulator of steroid hormone signaling, alter the
genomic response to glucocorticoids (GCs). There are thousands of known mutations in the GR, and likely
many more that have yet to be observed. For nearly all of those variants, the effects on GR activity are
unknown. Further, the prevalence of specific GR variants differs across populations and may contribute to the
diverse range of individual responses to pharmaceutical and physiological stimuli signaled though the GR. This
proposal directly addresses how variation (GR mutants) impacts phenotype (gene expression) by testing my
central hypothesis that genetic variation in the GR alters subsets of the genomic GC response by modifying
interactions with other TFs and co-factors. Guided by preliminary data, I will test my central hypothesis by
completing two Specific Aims. In Aim 1, I will simultaneously measure, in a single assay, the effects of 194
mutant GR genotypes on GC-responsive gene expression via a high-throughput reverse genetic screening
platform. I will test GR coding variants that are either pathogenic, preclude post-translational modification, or at
the extremes of positive or negative selection. Changes in the GC-responsive transcriptome will identify loss-
of-function, sub-pathological, and benign coding mutations thus yielding an empirical pathogenicity score for
each variant. In Aim 2, I will measure how specific clinically relevant GR mutations alter the genomic response
to GCs and ultimately perturb cellular function in three independent homozygous tagged mutant GR cell lines.
These Aims leverage my existing skill sets and domain expertise against training in genome editing, single-cell
technologies, and statistical analyses I require to achieve scientific independence. To aid my transition to
becoming an independent investigator, I have formed an interdisciplinary Advisory Committee composed of
leading scientists at my institute. This committee will advise on my research and professional progress,
including providing feedback on tenure-track job applications and grants. I will use my accomplishments under
this award to publish peer-reviewed manuscripts in high impact journals, secure a tenure track position at an
R1 institute, and obtain independent NIH funding. Completion of the research training outlined in this proposal
is a significant step towards my long-term goal of leading an independent laboratory focused on
determining how genetic variation influences gene expression responses to endocrine signals.

Public health relevance
PROJECT NARRATIVE Identical stimuli elicit pathophysiological endocrine responses in some individuals but not others. Exhaustive genetic dissection of the glucocorticoid receptor, the primary mediator of glucocorticoid endocrine signaling, has not been performed despite recognition that mutations in this factor can alter the genomic glucocorticoid response. In this proposal, I will use high-throughput targeted mutagenesis and functional genomic approaches to identify subsets of the genomic glucocorticoid response that depend on specific glucocorticoid receptor domain functions and co-factor interactions.